American Society for Virology Meeting- Jr Investigator Support

The American Society for Virology (ASV) seeks renewal of a multi-year block grant to provide partial support
for predoctoral students, postdoctoral fellows, and U.S. teachers of undergraduate virology to travel to and
participate in the annual ASV scientific meetings in 2021-2025. The ASV 2021 meeting will be held July 17-21
at the Palais des Congrès de Montréal, Quebec, Canada, in conjunction with local hosts from McGill
University; the subsequent 4 meetings will be held at US venues. Travel awards are awarded with emphasis
on participation by women and underrepresented minority virologists, with the goal of benefiting future virology
research. Pre- and postdoctoral awards will be $500 each, and teacher awards $1,000 each, for a total of
$14,000 per year. Members of the ASV Travel Award Committee will evaluate the applications. Pre- and
postdoctoral awardees are selected based on an abstract of their work for presentation in workshops or poster
sessions. Teachers are selected based on an essay explaining the benefit of ASV meeting attendance to their
teaching (and research, if applicable). In addition to announcing the travel award program to its members, ASV
promotes it to ~100 U.S. undergraduate institutions serving primarily underrepresented populations. Post-
meeting evaluations are required of awardees and obtained anonymously, focusing on how they benefited
from participation. The ASV meeting provides an opportunity for U.S. junior scientists to meet and interact
directly with senior virologists in symposia, workshops, poster sessions, and special satellite symposia
covering the most recent developments in virus research. These include studies of viruses of humans, animals,
plants, invertebrates and prokaryotes, and the scope spans topics such as virus genetics, replication, structure,
pathogenesis, ecology, evolution and emergence, disease control, virus-host interactions, and new
technologies. The ASV is the largest general virology meeting in North America, enhancing opportunities for
cross-fertilization of ideas and technologies across the entirety of the virus world. In addition to scientific
sessions, over the last 10 years the meeting has included opportunities for trainees and teachers of
undergraduate students to network with and receive mentoring from virologists with experience in academia in
both research and primarily undergraduate institutions, industry, government research, publishing, clinical
virology, and other scientific careers through career, education, and communication workshops and lunch
discussion tables with senior scientists. The ASV annual meeting positively impacts U.S. efforts in public health
and research needed to effectively combat viral diseases. The ASV has actively and successfully increased
the diversity of speakers and participants, and it has a strong ethos of promoting the development of the next
generation of virologists through ample opportunities to actively present their research and participate in ASV.
Travel awards to trainees and teachers of undergraduate students are the foundation of this mission of ASV.
.

Public health relevance
Narrative The American Society for Virology (ASV) fosters the training of junior virologists and teachers of undergraduate virology by encouraging their participation at its annual general meetings. ASV’s annual meeting is the only large general virology meeting in North America. The breadth of virology covered enhances collaborations and opportunities for cross-fertilization of ideas and technologies across the whole of the virus world. This contributes to meeting the health promotion and disease prevention objectives of the NIH mission. There remain major threats to domestic and international health from new and emerging virus diseases, such as the SARS-CoV-2 pandemic of 2020, in addition to more familiar viral diseases that are not yet controllable. This makes the continued training of junior investigators and undergraduate teachers in virology highly relevant. .